TASK A10: TEST CANDIDATE THERAPEUTICS AGAINST PAPILLOMAVIRUSES

This contract provides for the development of new and refinement of existing models of infectious diseases and may include evaluation of candidate countermeasures.